The Washington University Center for Diabetes Translation Research

- Dissemination and Implementation in Diabetes Research Core
The primary goal of the Dissemination and Implementation in Diabetes Research Core (DIDR) is to assist Washington University Center for Diabetes Translation Research (WU-CDTR) investigators in filling the gap between discovery of new knowledge generated by their diabetes research and the application of this science to ultimately inform and benefit patient and population health. The DIDR Core has been critical in expanding the cadre of investigators conducting translational research in diabetes and building novel partnerships. Over the past five years, the Core has contributed to the evolving research methods that support high quality dissemination and implementation (D&I) studies including innovative research designs, novel D&I strategies, specialized measures assessing current research and practice related to D&I in diabetes interventions, and methods to understand context and tap preferences. Additionally, D&I methods support research conducted within clinical and community settings that represent real-world practice, which necessitates specialized methods to fit research within the normal operating procedures of practitioners and organizations.
The DIDR Core actively supports WU-CDTR investigators by providing expertise and resources in D&I science to advance health. The Core also supports clinical and academic partnerships and those that extend to community contexts and non-healthcare sector organizations with missions that directly address determinants of health and reach populations that can benefit from effective interventions and
approaches for diabetes prevention and management. Current DIDR Core services build on this experience in implementing DIDR activities and supporting the large number of investigators pursuing D&I research. Based on this successful history, promising trajectory, and systematic core evaluation, we expect continued growth of DIDR services to support D&I research of WU-CDTR investigators.

Public health relevance
Overview The Washington University Center for Diabetes Translation Research (WU-CDTR) supports research on the multiple causes of diabetes burden. The Center includes five novel Translational Research Cores: Dissemination and Implementation in Diabetes Research; Artificial Intelligence and Data Science; Health Communication and Social Needs; Health Informatics in Diabetes Research (Regional Resource); and Intergenerational Research via Home visiting Networks (National Resource); and sponsors a Pilot and Feasibility Program and an Enrichment Program. The WU-CDTR enhances efficiency, productivity, and rapid research translation across a national network of investigators while fostering collaborations to reduce the burden of diabetes and improve health for all populations.